Identification and characterization of children with asthma-associated comorbidities through computational and immune phenotyping

PROJECT SUMMARY
Asthma, the most common chronic disease among children, is one of the five most burdensome diseases in the
US. While current care and research efforts focus on symptom control and exacerbation risk, children with asthma
may suffer from infectious and inflammatory diseases, ie, asthma-associated infectious and inflammatory disease
comorbidities (AIICs) (eg, pneumococcal disease, herpes zoster, appendicitis, and celiac disease). Although AIICs
pose serious threats to children with asthma, they are largely under-recognized, as evidenced by diabetes mellitus
being widely recognized but a less common chronic illness with a magnitude similar to that for asthma. Presently,
the mechanisms underlying AIICs are unknown. We postulate immunosenescence might be related, as AIICs
coincide with cardinal immunosenescence features. AIICs are not clinically defined and a suitable tool has not been
developed to identify children with AIICs. Thus, no strategies mitigating AIICs risks and outcomes exist.
Addressing these knowledge gaps depends upon two key questions: (1) “How can asthmatic children subgroups
with increased AIICs risk be identified at a population level using electronic medical records?” and (2) “What
immune parameters characterize such children?” Answering these is this proposal's primary goal. To this end, our
current R01 study successfully developed, validated, and implemented natural language processing (NLP)-
empowered computational phenotyping algorithms for two existing criteria for childhood asthma (Predetermined
Asthma Criteria, PAC and Asthma Predictive Index, API). NLP-empowered algorithm application to the 1997-2007
Olmsted County Birth Cohort (OCBC) enabled us to profile a subgroup of children with asthma at increased AIICs
risk, disproportionately represented by children who met both NLP-PAC and NLP-API.
Our new pilot data suggest
asthma potentially accelerates immunosenescence leading to AIICs in a subgroup of asthmatic children.
In this renewal proposal, we target this subgroup who meet both NLP-PAC and NLP-API. We will develop and
apply NLP-empowered computational phenotyping algorithms for AIICs to identify such children at a population
level, then characterize their immune parameters measuring immunosenescence. In Aim 1, we will develop new
NLP-empowered computational phenotyping algorithms for recognized and unrecognized AIICs (NLP-AIIC) for
children enrolled in Mayo Clinic `s 1997-2016 OCBC,
then assess portability of NLP-AIIC at Sanford Children's
Hospital, Sioux Falls, SD
. In Aim 2, we will identify and characterize children with AIICs through new NLP-AIIC and
NLP algorithms for asthma status, by utilizing clinical and immune parameters to measure immunosenescence. In
Aim 3, we will assess changes (eg, waning adaptive immunity) over time in immune parameters measuring
immunosenescence for 300 children in our R01 study, re-enrolling them for further characterization.
This proposed study is indispensable to understanding why some children with asthma develop AIICs, while others
do not. This knowledge will allow us to identify, manage, mitigate, and improve outcomes for AIICs among children.

Public health relevance
PROJECT NARRATIVE Although asthma is the most common chronic disease among children in the United States, its impact on the risk of serious infections and inflammatory diseases is under-recognized. Presently, it is unknown 1) how to use electronic medical records to identify asthmatic children at increased risks of asthma-associated infectious and inflammatory disease comorbidities (AIICs) and 2) which immune parameters characterize such children. Addressing these two questions is this proposal's primary goal since this knowledge will help us strategize early identification of asthmatic children susceptible to AIICs, eventually mitigate risk of AIICs in children with asthma, and improve patient outcomes.